Analytic Core

Analytical Redox Core – Project Summary
The South Carolina COBRE in Oxidants, Redox Balance and Stress Signaling (Redox COBRE) Analytical Redox
Core (ARC) offers infrastructure, expertise and training to Center members to support the successful application
of quantitative techniques for the study of redox homeostasis and cellular bioenergetics. This includes unique
approaches, technologies and equipment specific to the detection of redox-sensitive molecules and enzymes
that drive redox homeostasis. The aims of the ARC are to: provide investigators with advanced capabilities in
quantitative analytical redox biochemistry; state-of-the-art bioenergetic profiling; analysis and characterization of
redox signaling pathways; and in particular, expert mentoring, education, training and consultation with COBRE
personnel are top priorities of the ARC. Thus, we are able to impart the importance of redox signaling pathways
in human disease, ensuring ongoing Core utilization and development of our user base, while enabling scientific
discovery by COBRE investigators and the greater MUSC research community. During Phase III, we will
integrate key resources (e.g., Seahorse XF bioenergetics profiling assays) previously available through the
Bioenergetics Core that is now no longer available. Combined with our expertise in analytical biochemistry, the
Phase III ARC aims to provide COBRE members with a multidisciplinary and comprehensive suite of services
for quantifying ROS/RNS species and redox-modified proteins as well as characterization of their impact on
bioenergetic networks and pathobiological processes.